Resubmission: Multilevel Strategies & Tailored HIV Prevention & Care for Young Couples who use Alcohol & Other Drugs Across Cape Town

PROJECT SUMMARY/ABSTRACT
The proposed supplement seeks to address barriers and test new facilitators for recruitment and uptake of
PrEP and ART for the biobehavioral Couples Health CoOp Plus (CHC+) intervention, and for the stigma-
reduction intervention at the structural level within communities. It is critical to note that the CHC+ parent
study stigma intervention was originally awarded to take place in community clinics and has shifted to
communities due to the COVID pandemic. With these changes, the CHC+ parent study is delayed as the
project faces multiple daily barriers with recruitment that slow study progress, including documented
community violence, protests, gang violence, and community unrest. The CHC+ team is also adjusting to
continuous rolling power outages, which include not only electricity supply but also increased travel time
caused by traffic lights being out, and reduced communication with participants caused by mobile network
coverage blackouts. Additionally, there are continued high rates of substance use—including heavy alcohol,
methamphetamine, and methaqualone with marijuana use—as documented in our preliminary behavioral
and biological data. Supplement Goals: Through this supplement, we will aim to better define the
community barriers for recruitment and retention. We will also develop strategies to reduce these barriers
and increase facilitators for recruitment and retention, and to test them. Consequently, we propose a
combination of supplementary approaches, including an environmental scan through police reports, daily
reports from staff, in-depth interviews, and focus group discussions with community members; and then to
test these new strategies for successful study completion. The proposed Supplement Specific Aims are:
Aim 1. To examine how a constellation of violence, drug use patterns, and changes in structural conditions
act as barriers to enrollment, intervention engagement, and retention of the couples and community
members within each study community. Aim 2. To implement and test peer navigators as facilitators to
reduce barriers to recruitment and engagement in both the CHC+ and Community Stigma reduction
interventions and complete follow-up appointments successfully.
Public Health Impact: The COVID pandemic has challenged and complicated the commitment to end HIV.
The loss of jobs, increased community and gang violence, and persistent heavy substance use pose a
significant risk for participants in health studies in Cape Town, as do power outages for staff members who
are recruiting using community-based approaches. This supplement has the potential to identify solutions
and prove that peers can overcome these intersectional barriers and become ambassadors within their
communities to safely increase participant recruitment and uptake in health research interventions. There is
also the potential to address the HIV care cascade to end HIV and translate these strategies to other regions
with more grassroots and sustainable solutions.

Public health relevance
Project Narrative With ongoing challenges such as community violence, COVID-19 and related resource shortages, an ongoing energy crisis, joblessness, and labor strikes, the parent study has faced multiple challenges in recruiting participants. To overcome these difficulties in recruiting couples who use substances and implementing both a couples and stigma-reduction intervention, new and innovative strategies are necessary to ensure that the completion of the parent study is successful in helping to end the HIV epidemic. Through informative focus group discussions and in-depth interviews, as well as additional recruitment and outreach support through the innovative use of peer navigators and communication captains this project will increase its capacity to reach for both interventions, and steer away from communities that are in turmoil.